Stiff, solid microenvironments induce Chromosome loss and challenge Epigenetic therapies

ABSTRACT:
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-
CA-24-029. Our proposed projectfacilitates a new collaboration and introduces Asst Professor Karmella Haynes
as a newInvestigator to NCI and its PSON Program. Our parent award U01-CA254886 has begun yr-4 and
focuses on solid tumors and genetic instability through development of novel fluorescent `ChReporters'. These
enable us to image and track the first induction of chromosome loss and propagation into colonies. This is
expected to decrease the levels of Tumor Suppressors (e.g. p53, PTEN, APC, etc.), which is understudied in
these contexts and is the focus of our efforts. The Haynes lab brings deep expertise in epigenetics including
regulation of Tumor Suppressor genes, which are a major challenge in cancer, because loss of these key factors
is a major modern challenge to rescue (and lagging behind successes in inhibition of Oncogenes). Solid tumors
exhibit more chromosome losses and gains than liquid tumors, and clinical efforts with epigenetic drugs that
possibly rescue Tumor Suppressor levels to some extent are showing better efficacy in Liquid tumors. All of this
motivates our studies of chromosome loss using our ChReporters in Solid Tumor models to address how such
drugs as well as molecularly specific CRISPR approaches affect Tumor Suppressor levels and cancer-related
phenotypes.

Public health relevance
Project Relevance to Public Health This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA- 24-029, and relates to a funded parent award U01-CA254886 focused on genetic changes in solid tumors based on our novel ways for monitoring in live cell changes. Because changes in Tumor Suppressor levels is a well documented risk factor for many cancers, we focus here on their levels and mechanisms of changing them in relation to Chromosome loss – making use of our novel ChReporter methods that provide evidence of physically driven changes to chromosome number. We focus on epigenetic drugs emerging in the clinic and also take gene-specific CRISPR-activation & inhibition approaches to help clarify impacts of chromosome loss on expression levels of key Tumor Suppressors as well as Oncogenes. The work recruits into the NCI and its PSON anew collaboration and newInvestigator, Professor Karmella Haynes.